Michigan Center for Urban African American Aging Research

Overall Abstract
The Michigan Center for Urban African American Aging Research (MCUAAAR), a mature social
and behavioral science center of the Resource Center for Minority Aging Research program,
proposes to expand its reach and impact by mentoring junior faculty (most of whom will be
African American) and by focusing on African American Life-course health research. Michigan
State University (MSU) will formally join the University of Michigan (UM) and Wayne State
University (WSU) to form the new MCUAAAR. Our three specific aims include: 1) Increase
reach and coverage by including Michigan State University as a full partner in the MCUAAAR;
2) Recruit and mentor 15 new junior researchers; and, 3) Increase important research on the
life-course experiences of older adults of diverse ethnic and racial populations, especially
African Americans. Four cores are proposed in this application; Administrative, Analytic, REC
and CLRC. We will employ an integrative approach to mentoring, entailing a structured set of
activities and training across the pilot funding period: (a) Formal goals will be set at the
beginning of the pilot and reviewed in monthly MCUAAAR meetings; (b) Based on the goals set,
a mentoring team will be assembled to assist with research, dissemination of findings, and
research translation; (c) A set of training activities in scientific writing, measurement, and
community-based research partnerships will be conducted each year; (d) A formal six-month
evaluation will be conducted and shared with the MCUAAAR faculty; and, (e) During the second
year, an ongoing MCUAAAR mentor will be assigned to assist with publications and grant
preparation and provide support to junior researchers attending conferences. There will also be
opportunities for longer-term mentoring and training in the program. We continue to be
motivated by an NIH-funded series of studies (e.g., Ginther et al., 2011) in which applications
from black scientists were shown to be 10 percentage points less likely to obtain grant awards
than applications from white investigators; in practical terms, this gap means that white
applicants are about twice as likely as blacks to be approved and funded. The RCMAR program
has been important in helping to eliminate this gap for RCMAR researchers overall, and we
continue to focus on the importance of abolishing the disparity for African American researchers
in particular. We are also motivated by the continuing disparities in chronic disease and
mortality among older African Americans.

Public health relevance
Project Narrative The purpose of the MCUAAAR is to recruit, mentor, and develop the next generation of diverse NIH researchers engaged in research on the science and amelioration of health inequities and disparities among African American older adult populations.